Neonatal Stress in Very Preterm Infants: Longitudinal Effects on Epigenetics and Neurodevelopment

PROJECT SUMMARY/ABSTRACT
Preterm birth affects 1 in 10 infants born in the United States, resulting in significant morbidity and economic
cost. Children who are born very preterm (VPT; gestational age<32 weeks) have increased risk for impaired
neurodevelopment. VPT infants experience increased physiologic stress while their caregivers experience
increased psychological distress—both are associated with impaired neurodevelopment. Epigenetic
modifications are proposed as a possible mechanism linking physiologic stress and neurodevelopment in VPT
infants. The main objective of the proposed research is to identify the mechanisms by which neonatal physiologic
stress induces epigenetic modifications that contribute to impaired neurodevelopment, as well as how caregiver
distress moderates the relationship between longitudinal neonatal physiologic stress and neurodevelopmental
outcomes. Specifically, the proposed research aims to (1) create and validate novel indices of neonatal
physiologic stress in VPT infants; (2) identify the effects of neonatal physiologic stress on epigenetic
modifications and later neurodevelopment in VPT infants; and (3) determine the effects of caregiver distress on
neurodevelopment in VPT infants. This aligns with the NICHD Strategic Plan 2020 scientific priority—to reduce
the incidence of neurodevelopmental disorders by improving the understanding of their origins in the
developmental process and identifying potential targets and optimal timing for intervention. The training plan
includes several components necessary to reach the PI’s goal of becoming an independent clinical scientist,
studying early life risk factors and etiological mechanisms in neurodevelopmental disorders. Specifically, the
proposed training aims to enhance the PI’s molecular genetic expertise by adding training in epigenetic analyses
via intensive workshops and laboratory experiences with an expert mentor and to expand the PI’s quantitative
expertise to include complex longitudinal analyses. The new education and training on neonatal physiological
stress will provide the PI with unique expertise that will lead to new avenues of investigation. Finally, the PI will
develop professional development skills that will be critical for success as a tenure track assistant professor and
independent clinical scientist. The academic environment at the University of Iowa is well-suited for the proposed
research and training. Faculty members with expertise in advanced quantitative methods, epigenetics, and
neonatal physiology are willing to provide expert mentorship to the PI. The Division of Neonatology conducts
numerous research studies on preterm birth each year and has the infrastructure, including an outstanding team
of clinical research nurses and a high-risk infant follow-up clinic, to support the proposed research. The Iowa
Institute of Human Genetics provides researchers with a state-of-the-art, high-throughput genetic analysis facility
and supports research focused on human genetics. Numerous institutional organizations provide a variety of
opportunities to develop the skills necessary for success as an independent clinical scientist.

Public health relevance
PROJECT NARRATIVE There is a need to uncover the etiological mechanisms underlying the association between preterm birth and impaired neurodevelopment, both to improve the identification of the preterm infants who are at higher risk for impaired neurodevelopment and to inform efforts towards neurodevelopmental interventions. This project will provide much needed data to pave the way for novel opportunities for neurodevelopmental prevention and intervention efforts for preterm infants, and thus, decrease the incidence of neurodevelopmental disabilities and morbidities.